Multidisciplinary Training Program in Basic Diabetes Research

Abstract
The burden of diabetes and its complications underscores the continued need to train the next
generation of well-qualified scientists to develop new ideas and novel therapies for the treatment,
prevention and cure of diabetes. The primary goal of this training grant is to prepare PhD basic
scientists for careers in diabetes research. The training includes multidisciplinary and comprehensive
learning experiences, as well as the mentorship and laboratory research experiences required to
develop a deep understanding of the molecular aspects of diabetes. This training program is embedded
within the rich research environment of the University of Michigan, which includes a highly collegial,
interdisciplinary diabetes research community with outstanding core resources to support biomedical
research. The training program builds on the unique expertise of preceptors, which fall into six major
interest groups – islet biology, autoimmune diabetes, adipocyte biology, hypothalamic regulation of
metabolism, mechanisms of insulin resistance and metabolic control (liver, adipocyte and muscle
groups), and diabetes complications. The program includes training that occurs within individual
research laboratories, but is supplemented by a core curriculum - with lectures on molecular
pathogenesis of diabetes, cell and developmental biology, responsible conduct of research, and
research methodologies. In addition, the trainees attend a variety of interdisciplinary seminars, activities
in grant writing, career strategy workshops, and meet with visiting speakers. The Director mentors the
trainees in individual and small group sessions. This training is designed to provide the necessary tools
for transition to independence. This program includes 27 mentors in a highly collaborative environment,
all with stable extramural funding. The mentors are diverse in their area of specialty, with appointments
in Schools of Kinesiology, Literature Sciences & Arts, and many departments and divisions within the
School of Medicine. This program will provide a significant complement for the missions of the Michigan
Diabetes Research Center and the Nutrition and Obesity Research Center, which support research
infrastructure but provide no support for postdoctoral trainees. This training program will be overseen
by an executive committee comprising the Principal Investigator and co-director, plus three members
all of whom are senior investigators with strong mentoring track records.

Public health relevance
Project Narrative Our program provides basic scientists with a deep understanding of the molecular aspects of diabetes through strong laboratory-based research experiences, excellent mentorship, and an academic environment with a focus on multidisciplinary and comprehensive diabetes research. Training is a combination of immersion in specific research projects under the direction of experienced and accomplished senior researchers, formal education, and participation in a variety of other research- related educational activities. This training program fills a critical need to increase the number of future leaders in diabetes research.